Threat Interpretation Bias as Cognitive Marker and Treatment Target in Pediatric Anxiety

PROJECT SUMMARY
The proposed phased innovation grant will test personalized cognitive bias modification as a novel
intervention to reduce interpretation bias and, subsequently, anxiety in clinically anxious youth.
Anxiety is the most common mental health problem across development, affecting one in four children and
adolescents. In response to data that evidence-based interventions are ineffective for a substantial proportion
(~50%) of youth, experts have called for development of novel treatments that directly target underlying
mechanisms. One such promising mechanism is interpretation bias, the inaccurate attribution of threat when
faced with ambiguity. We have previously demonstrated that interpretation bias is a ubiquitous marker of
anxiety in children and adolescents, and therefore may be an ideal treatment target. Cognitive bias
modification for interpretation bias (CBM-I) is a computerized intervention that attempts to reduce anxiety
symptoms by directly reducing interpretation bias. In CBM-I, participants are provided with real-time corrective
feedback when they select threat-relevant interpretations of ambiguity, with the expectation that they will learn
to automatically make more neutral (rather than threat) interpretations over time. CBM-I has demonstrated
preliminary efficacy in adults for reducing anxiety symptoms. Yet extant data on CBM-I in clinically anxious
youth are sparse, with little examination of interpretation bias as a malleable target and mechanism of
action. To date, several critical questions remain to be answered: 1) is the targeted mechanism (interpretation
bias) modified by CBM-I in youth?; 2) what dose reflects meaningful interpretation bias change?; and 3) does
anxiety reduce because of reductions in interpretation bias? In response to RFA-MH-18-704, we use an
experimental therapeutics approach to test interpretation bias as a putative intervention target with
CBM-I. This proposal includes a two-phased study of personalized CBM-I in youth ages 10 to 17 who meet
diagnostic criteria for anxiety disorder (generalized, social, separation). In the R61 Phase (N=36), a
randomized controlled trial (RCT) examines whether and at what dose CBM-I personalized to youths’ individual
anxiety symptoms reduces interpretation bias compared to a matched computerized interpretation control
condition (ICC). In the R33 phase, an RCT (N=66) validates target engagement and conducts a mechanism
test (i.e., whether anxiety reduction is due to interpretation bias reduction) by comparing personalized CBM-I to
cognitive restructuring, a clinically relevant psychosocial intervention that also targets anxious cognition.
Strategic design decisions based on the extant literature in both adults and youth will maximize the
likelihood of target engagement. If successful, this experimental intervention could represent a significant
step forward in developing personalized treatments that directly modify processes underlying youth
anxiety, with potential for clinical translation into real-world clinical and community settings.

Public health relevance
PROJECT NARRATIVE The current proposal addresses a need for novel experimental therapeutic approaches to directly targeting cognitive mechanisms underlying anxiety in children and adolescents. Building on our prior work and existing literature that identifies interpretation bias as a marker of youth anxiety, we propose a personalized cognitive bias modification intervention to target threat interpretation bias (CBM-I). In a two-phased study, we test CBM-I as an experimental intervention that may significantly reduce interpretation bias, and subsequently reduce anxiety symptoms, in clinically anxious youth.